1/2 Treating Mothers with ADHD and their Young Children Via Telehealth: A Hybrid Type I Effectiveness-Implementation Trial

ABSTRACT/PROJECT SUMMARY
Maternal ADHD, present in 25-50% of families of children with ADHD and frequently untreated, interferes with
effective parenting and predicts poor child developmental and behavioral treatment outcomes. Based on the
literature and our own pilot data, we will randomly assign mothers with ADHD and their young at-risk children
to one of two conditions: (1) stimulant medication for mothers with ADHD followed by a child treatment strategy
(CTS) beginning with behavioral parent training (BPT) with the added recommendation of child stimulant
treatment if the child remains impaired or (2) a CTS without treatment for maternal ADHD on parent, child, and
family outcomes. We will examine target mechanisms including improvements in maternal ADHD-related
impairment and symptomatology (attention, impulsivity, emotional regulation), parenting skills, and BPT
engagement, as well as treatment moderators (baseline maternal ADHD severity, maternal impairment, and
parenting skills). Moreover, in an effort to develop a model of treatment that has potential for widespread
dissemination while also reducing barriers to receiving care, we will screen mothers for ADHD in primary care,
where child ADHD is most often identified and treated, and co-located mental health providers will deliver
treatments via telehealth. Development of an implementation plan and associated toolkit using a stakeholder
participatory strategy will enhance the ability to move efficiently to adoption of this approach. In addition, we
will study the care delivery context, assessing procedures for and rates of screening and participation as well
as staffing, workflow, provider- and patient-level acceptability, readiness, and feasibility of implementation
approaches. This hybrid effectiveness-implementation project will be achieved via a collaborative R01 across 2
research sites in the US (N = 240 families), with 4-5 primary care partners at each site.

Public health relevance
PROJECT NARRATIVE Attention-Deficit/Hyperactivity Disorder (ADHD) is a common, disabling and highly familial disorder that interferes with effective parenting and child behavioral treatment response when present in mothers, and is frequently left untreated. This hybrid implementation study will evaluate two innovative and scalable treatment strategies delivered via telehealth by co-located mental health providers: maternal stimulant medication plus a child treatment strategy (consisting of behavioral parent training plus child stimulant medication if the child remains impaired) vs. the child treatment strategy only. This project holds promise for modifying the course of ADHD in young children whose mothers also have ADHD in a manner that reduces barriers to health service delivery and holds potential for widespread dissemination.